University of Minnesota Clinical and Translational Science Institute (UMN CTSI)

Clinical and translational science (CTS) is at the crossroads of major technology advances
requiring strong academia–community partnerships anchored in trust for the effective and rapid
deployment of best practices. The UMN CTSA Hub will build on proven commitments to
accelerate impactful CTS. Aim 1 will provide novel infrastructure to reduce research barriers and
accelerate translation to practice via a new Office of Clinical Research and Community Affairs.
This office will augment CTSI’s capacity to respond to and facilitate robust and sustainable
community relationships that extend beyond single investigator projects. Aim 2 will deliver highquality
and efficient research services and resources through the Clinical Research Support
Center (85 staff) that will lessen trial barriers and support all aspects of study design, biostatistics,
bioinformatics, regulatory compliance, contracting, and more. Expanding representation in clinical
studies will strengthen connections to the state’s broad population. A learning health system
(LHS) and continuous quality improvement program will expedite the implementation of novel
enhancements. Aim 3 will cultivate and train a capable and well-prepared CTS workforce with
new tools and programs; develop and test novel trial processes and participant satisfaction; and
disseminate and implement learnings locally and nationally. Tailored enhancements will
personalize CTS training for community, academic, and workforce professionals, including
improved informed consent processes, an investigator primer, a research career development
series, and more. CTSI’s Rural Health Program offers a postdoctoral fellowship in health policy
and leadership and a year-long training program for community leaders. Training with community
health workers (CHWs) will strengthen engagement with Minnesota’s communities. Aim 4 will
foster leadership, team science, and data sharing to support collaborations through leadership
programs, professional coaching, vertically integrated retreats, team function seminars,
Innovative Team Science programs adapted for early career faculty, and incentives to gain CTSI
leadership skills. Health Informatics will support advanced data management and analytic
infrastructures integrated with electronic health record and LHS systems. Aim 5 will address
barriers to health access by deploying evidence-based and improved research practices to train
CHWs and Hub Partners for broad community input and decision-making. We will build a
national, population-level geo-database of quantifiable measures using novel Multidimensional
Measures of health and the environment in a Healthy Communities Data Portal. This portal will
link health and clinical data to define national impacts on access to care, study enrollment, data
collection, and more with validation projects on telehealth and education and early childhood
cognitive function after prenatal methamphetamine exposure. Impact. With a robust
infrastructure, the next generation of research leaders, and a well-trained workforce, our Hub and
regional community will co-develop and implement CTS advancements to improve health.

Public health relevance
The University of Minnesota's Clinical and Translational Science Institute, together with its Partners and Collaborators, will find better, faster ways to bring scientific advances to real-world use. To do this, we will reduce research barriers, provide high-quality services for researchers, foster and train a multidisciplinary research workforce, broadly share findings, build sustainable relationships with our Minnesota communities, and more. This work, combined with our focus on health access, quality, and impact, ultimately aims to make healthcare better for everyone.